Direct and Indirect Targeting of HIV Tat for Selective RNA Degradation and Protein Suppression

Project Summary/Abstract:
The persistence of latent reservoirs of HIV-infected CD4+ T cells presents a critical barrier to achieving
a cure. These reservoirs harbor replication-competent HIV proviruses that evade immune detection and viral
cytopathic effects, enabling long-term survival despite antiretroviral therapy (ART). Innovative strategies are
needed to disrupt latency, suppress viral protein expression, and selectively eliminate infected cells. We aim to
develop and evaluate novel CRISPR-Cas13-based therapeutic approaches to target HIV-infected cells and
sensitize them to cell death through direct viral RNA degradation and host pathway modulation. The overarching
goal of this study is to evaluate and optimize a dual-pronged approach combining CRISPR-Cas13d-mediated
degradation of HIV Tat mRNA and CRISPR-Cas13b-mediated targeting of host PI3K pathway components to
sensitize infected cells to apoptosis. The specific aims are as follows:
AIM1. Assess the efficiency and specificity of CRISPR-RfxCas13d in degrading Tat mRNA in CD4+ T cells
from people living with HIV on suppressive ART. We will use a lipid nanoparticle (LNP)-based delivery
platform capable of transfecting CD4+ T cells with high efficiency. Single-cell RNA-seq (HIV-seq), and digital
PCR will measure changes in HIV RNA and protein expression. Additionally, novel Cas13 orthologs with
enhanced collateral activity will be characterized and test their ability to selectively deplete HIV-infected cells.
AIM2. Develop strategies to sensitize HIV-infected cells to apoptosis through PI3K pathway targeting.
The PI3K pathway plays a key role in maintaining HIV latency and infected cell survival. Using CRISPR-Cas13b,
this aim will target specific PI3K effectors, such as PI3K p110, p110 and TNFAIP8, to induce apoptosis in
infected cells. Synergistic effects of PI3K inhibition and Cas13d-mediated Tat mRNA degradation will be
evaluated to determine the optimal strategy to test in an animal model.
AIM3. Validate the efficacy of the combined approach in HIV-infected humanized mice. The candidate
therapeutic strategy will be tested in a humanized mouse model of HIV infection (HIV-HIS) allowing for preclinical
evaluation of Tat RNA and protein degradation, reservoir reduction, and delay in viral rebound following ART
cessation. LNP-delivered CRISPR constructs will be optimized for dose and targeting specificity and their effects
on HIV RNA, protein expression, and reservoir size will be characterized.
This study integrates cutting-edge RNA-editing technology with enhanced activity, leveraging a novel
LNP platform, to disrupt HIV latency and promote infected cell elimination. The work will advance our
understanding of mechanisms of Tat mRNA degradation and PI3K inhibition for synergistic viral suppression and
reservoir reduction. This project has the potential to significantly advance curative strategies for HIV by
developing a novel therapeutic approach that directly targets both viral and host factors critical for latency and
persistence, offering a promising pathway toward durable HIV remission.

Public health relevance
Project Narrative This project aims to develop innovative RNA-targeting strategies to eliminate HIV proteins in infected cells, addressing a critical barrier to curing HIV. By combining advanced CRISPR technology with novel drug delivery systems, this research seeks to disrupt the mechanisms that allow the virus to persist in the body. The findings could lead to transformative therapies, improving the health and quality of life for people living with HIV worldwide.